SAFETY AND EFFICACY OF ZDV FOR ASYMPTOMATIC HIV INFECTED INDIVIDUALS

Randomized double blind study to determine the safety and efficacy of ZDV for asymptomatic HIV positive individuals with greater than 500 T cells. Patients receive ZDV is T cells drop below 500.